Mobius Accessibility Mounting System and Assistive Technology Product Line to Support Independence and Safety for Older Adults and Persons with Disabilities

Project Summary/Abstract
The overwhelming majority of older adults, age 65 and over, want to age in place at home, but many reach a
point in their lives where they can no longer live in their own home simply because they are unable to complete
their activities of daily living (ADLs) and move around their home safely and effectively. The facts are that only
10% of homes in the US have the accommodations needed for mobility (only 5.8% of the homes in
Pennsylvania and New York are considered “aging-ready”), yet an estimated 35% of older adults and most
people over age 85 have mobility limitations. These limitations are most often the result of the onset of multiple
chronic conditions including arthritis, heart disease and chronic lung disease. Mobility limitations can have life-
changing impacts even when the older adult is living with a companion because mobility limitations often result
in higher rates of disease, disability, and hospitalization due to falls. One in three older adults fall annually, and
one out of five falls in older adults result in serious injury. Falls are the leading cause of injury-related death
among adults ages 65 and older[1].
Home modifications and accommodations that make homes safer and more accessible include stair lifts, grab
bars, and bath/shower adaptations and renovations. However, the current fall-prevention products available in
the market are not meeting older adults' needs for mobility aids. Product innovation has stagnated, and too
often, tight spaces and placement restrictions make installation of grab bars and other devices difficult or
impossible. There is a significant need and consumer demand for an easily installable, reliable system that
allows end users to adapt mobility aids such as grab bars, railings, and other assistive devices in their homes.
The current situation for many people with mobility impairments is that even when an outdated product is
available, installation of these essential mobility assistance devices requires expensive contractors. And, once
installed, these devices are not able to be adapted by the end user as their needs evolve and change.
Our objective is to further develop and commercialize a novel system and attachments to improve the
accessibility of living spaces and serve as a foundation for mobility aids to support successful aging-in-place.
Once the product is installed, our modular, expandable rail system can be easily adapted with interchangeable
accessories that solve a range of mobility problems in the home. When not configured for a particular mobility
need, the rail can be hidden by a decorative cover to mimic architectural trim work. We have successfully
demonstrated feasibility of a system in the completed first phase of this project and now seek SBIR Phase II
funding to (1) perform a comprehensive design review and establish priority for developing attachments using
a focus group research approach; (2) redesign components, taking into account all feedback from the design
review, and manufacture production parts; and (3) perform studies to evaluate the usability of the product from
the perspectives of various stakeholders, and test its performance in the University of Pittsburgh Healthy Home
Laboratory and in the homes of volunteers. Upon completion of the grant, we will manufacture and distribute
the product through our own company, other home modification specialists, commercial and residential
contractors, direct-to-consumers online and in big box retail stores.

Public health relevance
Project Narrative This project will complete the development and commercial launch of a much needed and innovative accessibility system for homes and assisted living environments that will improve the safety and independence of individuals with mobility impairments. The Mobius system can easily be installed and adapted by the end user, caregiver or a handyperson and is comprised of ergonomic, aesthetically pleasing grab bars, handrails and assistive technology attachments that solve a range of mobility problems. Mobius fills a major gap in the market for home modifications and falls prevention technology to allow older adults to remain at home and successfully age in place.